COVID-19: HDL's Role in Innate Immunity and Cardiovascular Protection with COVID-19

COVID19: HDL’s Role in Innate Immunity and Cardiovascular Protection with COVID-19
The novel coronavirus (SARS-CoV-2) causes a disease called COVID-19. For many people, COVID-19 has
almost no symptoms, yet for others, COVID-19 is particularly dangerous and has high morbidity and mortality
rates. People with pre-existing type-2 diabetes and atherosclerotic cardiovascular disease (ASCVD) have twice
the risk of SARS-CoV-2 infection and are more likely to have poor outcomes. 70% of patients with ASCVD and
elevated troponin die of COVID. We don’t know what intrinsic factors contribute to these disparate outcomes.
High Density Lipoprotein (HDL) particles play a critical role in the innate immune system and are protective
against viral and bacterial infections. HDL particles best are known for their roles protecting from atherosclerotic
cardiovascular disease (ASCVD). The cardiovascular protection conferred by HDL is largely mediated by HDL’s
associated proteins, which comprise about half of HDL’s mass. Mechanisms for HDL’s protection from ASCVD
are shared with mechanisms for HDL’s protection from viral infections. These protective properties center around
the HDL-associated proteins that mediate its anti-inflammatory and antioxidative functions. The goal of this
project is to define how HDL may protect from Sars-CoV-2 infection and limit the inflammatory response to
COVID-19 illness. Obesity and type-2 diabetes (DM2) lead to hypertriglyceridemia and metabolic changes that
impair HDL’s anti-inflammatory and antioxidative functions. We will define if DM2 leads to HDL dysfunction and
contributes to severe COVID-19 outcomes.
Our overarching hypothesis is that HDL’s antiviral properties can limit SARS-CoV-2 infection and that HDL’s
anti-inflammatory and antioxidative capacity limit the systemic inflammatory response to COVID-19. We have
initiated a collaboration with Dr. Malall, an immunology expert running a large trial with COVID-19 patients whose
de-identified samples are paired with de-identified EMR outcomes data. In AIM1 we will test the hypothesis that
SARS-CoV-2 infection impairs HDL’s antioxidative and anti-inflammatory capacities, and that these changes can
be predicted by proteomic signatures of HDL. We also have collaboration with Dr. Denison, an expert in
coronavirus biology. In AIM2 we will test the hypothesis that HDL can reduce SARS-CoV-2 infectivity of lung
epithelial cells, but that COVID-19 impairs HDL’s antiviral capacity, which can be improved with Remdesavir
treatment. In AIM3 we will test the hypothesis that type-2 diabetes alters the HDL-associated protein networks
that limit systemic inflammation with COVID-19 and protect against SARS-CoV-2 infection.
Diabetes and cardiovascular disease are among the most prevalent problems among United States
Veterans, making Veterans more likely to have poor COVID-19 outcomes. An asset to this project is that we can
relate our HDL function and antiviral assays with clinical outcomes. Our studies will define proteomic signatures
from HDL that are important for its antiviral effects. We ultimately aim to use HDL-directed therapies like
recombinant Apo-A1 peptides to improve COVID outcomes.

Public health relevance
The novel coronavirus (SARS-CoV-2) causes a disease called COVID-19. For many people, COVID-19 has almost no symptoms, yet for others, COVID-19 is particularly dangerous and has high morbidity and mortality rates. Those among the highest risk of death from COVID-19 are people with pre-existing type-2 diabetes and heart disease. We don’t know what factors contribute to these disparate outcomes. The goal of our project is to test the properties of High Density Lipoprotein (HDL) in protecting from infection with the novel coronavirus, and limiting the worst inflammatory outcomes from infection. HDL is often thought of as the “good cholesterol” and is known for protecting from heart disease. HDL also has potent-antiviral properties. We don’t know yet which aspects of HDL mediate those anti-viral properties, and if they can be used to benefit patients impacted by COVID-19. Our studies will lay the groundwork for understanding HDL as a potential therapeutic for patients with COVID-19 which we expect to benefit Veterans who have high rates of obesity, diabetes, and heart disease.